Buffett Cancer Center Supplement to Strengthen Research, Training, and Outreach

Project Summary
The Fred & Pamela Buffett Cancer Center (also known as the Buffett Cancer Center) is the only
National Cancer Institute (NCI)-designated cancer center in Nebraska. The Buffett Cancer Center is a
matrix cancer center at the University of Nebraska Medical Center and its affiliated healthcare network,
Nebraska Medicine. The mission of the Buffett Cancer Center is to promote innovative translational cancer
research, excellence in cancer education and training, and outstanding patient-centered cancer care to reduce
the burden of cancer and cancer health disparities across Nebraska and beyond. Due to its specific
demographics, Nebraska needs capabilities in cancer research training and cancer disparities research targeted
to the American Indian, Hispanic, rural, and financially disadvantaged populations, which in Nebraska are
groups that substantially overlap. The Buffett Cancer Center (and the University of Nebraska as a whole)
encourages the entry of members of these groups into health careers by pathway programs for middle school,
high school, and college students. However, there is a growing necessity for strategies to bridge the
continuation of these underrepresented minority students further into graduate/professional programs and
faculty positions. Therefore, consistent with the mission of the Buffett Cancer Center and the goals of the NCI,
this administrative supplement extension will specifically address the need for cancer research training at the
level of predoctoral, postdoctoral, and early investigator scholars, with a focus on scholars with American
Indian, Hispanic, rural, and/or financially disadvantaged backgrounds. Our objective is to use focused
strategies to enhance the development of these scholars, thereby facilitating their readiness for successful
careers in cancer research and care and their ability to alleviate cancer disparities, and to assess the results of
our approach. Our Specific Aims for this supplement extension are as follows: (1) to sustain the guidance of
diverse scholars into cancer research pathways, (2) to maintain advancement of diverse scholars through
NCI workforce opportunities, and (3) to evaluate and disseminate the outcomes of this Training Navigator
Program. The Buffett Cancer Center is fully committed to attain progress in these Aims during the supplement
period and to sustain these efforts beyond the supplement extension’s conclusion.

Public health relevance
Project Narrative This supplement project extension is designed to strengthen research, training, and outreach by the Fred & Pamela Buffett Cancer Center with the goal of training predoctoral, postdoctoral, and early-stage faculty scholars from American Indian, Hispanic, rural, and financially disadvantaged populations, which are often overlapping populations within Nebraska. This project extension will focus on guiding diverse scholars into the pathway of cancer-related research training, optimizing their professional development and networking skills, and facilitating the advancement of these scholars through NCI workforce opportunities. In addition, during this project extension we will prepare to monitor the scholars’ success as they advance in their careers in cancer research and clinical care, and we will conduct evaluations of the training activities’ outcomes, complete project reports, and disseminate the knowledge gained from this project on best practices in mentoring these scholars.